Acute predictors of long-term post-trauma outcomes in youth victims of violence

Youth violence victimization is common and increases risk for a host of negative health outcomes, most
notably posttraumatic stress disorder (PTSD), which is the strongest predictor of poor quality of life following
trauma, even among those injured during the event. Given the potential harmful sequelae of trauma exposure,
it is crucial to identify acute post-victimization risk factors that predict chronic PTSD. At this juncture relatively
little data exists to aid in prediction of youth at risk for poor long-term adjustment following victimization or other
types of trauma, and there are no studies measuring relevant neural systems. Thus, our team aims to 1)
characterize acute post-victimization neurobehavioral predictors of risk for chronic PTSD with a focus on
prefrontal-subcortical function during processing of threat processing and frontoparietal networks for cognitive
control, and 2) use machine learning to identify the most robust set of predictors of chronic PTSD drawn from a
comprehensive assessment of youth neuroimaging, behavior and self-report, parent and family factors, and
neighborhood and community variables. Our team is well-prepared to successfully achieve these aims, as we
have relevant expertise in conducting prospective longitudinal assessment of acute neurobehavioral predictors
of risk for PTSD in adults (Larson), conducting longitudinal assessment of youth victims of violence (Levas),
and longitudinally characterizing neurobehavioral profiles of youth PTSD (Herringa). We will recruit youth
victims of violence aged 10-16 from the Emergency Department at Children’s Hospital of Wisconsin in
Milwaukee, and conduct comprehensive assessments at 2 weeks, 3 months, and 12 months following
victimization. To achieve a final sample of 200 youth at 12 month follow-up, we will recruit 240 youth,
oversampled for risk for PTSD based on currently available brief self-report indicators. Each assessment will
include measures of neural systems instantiating threat processing, including both reactivity to threat and
anticipation of unpredictable and predictable threat, and cognitive control, along with measures of PTSD and
other symptoms, cognitive functioning, family environment, social and school functioning, and
socioenvironmental factors (e.g. neighborhood disadvantage, discrimination). We will examine how acute post-
victimization variables (2 week) and early change following victimization (from 2 weeks to 3 months) predict
PTSD and other outcomes twelve months later. We will use both hypothesis-driven analyses focusing on a
priori specified regions and predictors, as well as comprehensive data-driven machine learning analyses. The
comprehensive assessment will allow for determination of the additional utility of neural markers for predicting
risk beyond previously identified self-report indicators. We expect this project to lead to identification of
predictors of risk for PTSD following victimization that are linked to underlying processes (hyper-responsivity to
threat, aberrant cognitive control) that can directly inform preventive interventions, ultimately improving the
quality of life for youth victims of violence.

Public health relevance
PROJECT NARRATIVE Identifying youth victims of violence most at risk for long-term post-traumatic distress is a pressing public health problem. This work seeks to identify dysregulation in neural circuitry supporting cognitive and affective processes two weeks after victimization predicts PTSD and other post-trauma symptom twelve months later. These data will advance our understanding of neurobiological factors associated with vulnerability to specific trauma-related pathology and provide an important step toward identifying appropriate early interventions in the wake of violence victimization.